CLINICAL SIGNIFICANCE OF AIRBORNE FUNGAL SPORES

The long-term objectives of this project are to provide an extensive catalog of the prevalence of airborne fungal spores and to develop reliable techniques for both the identification and quantification of specific allergenic components of certain fungal spores. There are three components of this study. (1) Establishment of fungal spores of the atmosphere will be accomplished by collecting spores with the Anderson sampler that aerodynamically separates the spores into size classes. Both cultural characteristics, and light and scanning microscopy will be utilized to both identify and quantify airborne fungal spores. (2) Isolation and characterization of some spore-specific allergens of some indoor and outdoor molds will be accomplished by using SDS- gel electrophoresis and isotachophoresis techniques. (3) Techniques involving electroblotting and enzyme immunoassay will be utilized to identify the full complement of antigens, including IgE-binding antigens or allergens within complex mixtures of proteins. Certain extracts of airborne fungal spores will be fractioned by SDS-gel electrophoresis, electroblotted onto nitrocellulose membranes and probed with sera from allergic patients, goat-antihuman-IgE and subjected to immunoenzyme staining. The cognate projects will provide information that is needed to understand the correlation between the onset and severity of respiratory allergic disorders and the prevalence of certain fungal spores. Also, they will provide information necessary for the development of reliable methods for both the detection and quantification of airborne allergens.